Engineered Developmental Microenvironments: Cartilage Formation and Maturation

Abstract
Articular cartilage lines the surfaces of joints and transmits the forces generated with loading; however, cartilage
can be damaged due to traumatic injury and disease and has a limited natural healing capacity. Although there
have been many advances in the development of cartilage therapies with autologous mesenchymal stromal cells
(MSCs), there is still much work to be done in order to identify the appropriate cell carriers and culture
environments that best promote the formation of functional cartilage. Our general approach for MSC-based
cartilage repair has been to engineer environments that recapitulate key developmental signals. Towards this,
in early funding cycles, we engineered hydrogel environments based on the biomolecule hyaluronic acid (HA),
including controlled degradation, growth factor presentation, and mechanical loading. During the most recent
funding cycle, we tethered and controlled the temporal presentation of a bioactive peptide (HAV) found in N-
cadherin, which is abundant in the developing microenvironment and mediates direct cell-cell communication. In
this renewal, we continue to address developmentally relevant cell-cell signaling, focusing now on indirect
communication mechanisms. Specifically, we recently found that a small fraction of differentiated chondrocytes
improves the amount and quality of matrix formation by MSCs and promotes their phenotypic stability. We further
showed that this phenomenon was the consequence of paracrine vesicle-mediated cell-to-cell signaling from
‘broadcasting’ chondrocytes to ‘receiver’ MSCs. Here, we hypothesize that both the production and reception of
these signals is regulated by the microenvironment (matrix stiffness, interaction with developmental ligands, and
molecular diffusivity of the embedding material). To address this novel hypothesis, the first Aim will utilize our
recently developed microenvironmental screening platform to determine the hydrogel formulation that optimally
supports MSC chondrogenesis in co-cultures of MSCs and chondrocytes. This will be achieved by spatially
varying peptide and encapsulating material properties and imaging early markers of chondrogenesis and
cartilage matrix formation to identify optimal environments. In the second Aim, hydrogel formulations that
optimize MSC chondrogenesis in co-cultures will be scaled up and evaluated over longer time courses and when
implemented in an injectable format that is compatible with current clinical workflows. In the third Aim, these
optimized formulations will be arthroscopically administered in clinically-relevant load-bearing porcine focal
cartilage defects to assess the efficacy of this cell delivery system to promote functional repair. Successful
completion of these Aims will identify new translational options for patients suffering from cartilage injuries.

Public health relevance
Narrative Articular cartilage enables efficient and pain-free transfer of load across joints with the activities of daily living, but is often compromised by traumatic injury and disease, and has a poor endogenous healing capacity. To address this, we develop a novel therapeutic approach that leverages the interaction between regenerative bone marrow derived mesenchymal stromal cells and a small number of chondrocytes delivered using customized micro-scale hydrogels. We further develop a clinically relevant delivery system and evaluate the potential of this new therapy to foster the formation of functional tissue in a pre-clinical large animal model of cartilage repair.